Scientific Information Management and Literature-based Evaluations for the NTP - Support for Publication

A number of complex scientific reports are prepared and peer reviewed under this contract and require support for publication of these lengthy and complex documents. Publication efforts include coordination of submission to the DNTP website as well as to NCBI Bookshelf. There are a number of activities to support templates for report development that must be compatible with .doc to XML and XML to HTML conversion softwares that are maintained under this project. Keywords: publication